Biological Insights from Genetic Investigation of ANthropometric Traits (GIANT) Across the Allelic Spectrum

Human genetics reveals underlying biological mechanisms for human disease susceptibility and quantitative
trait variability. Random inheritance of parental alleles provides a natural experiment to test genes for a causal
role in human phenotypes. Understanding the variants, genes, and mechanisms that underlie human
phenotypic variability can have important therapeutic implications – drugs whose targets are supported by
human genetic evidence are more likely to be efficacious. Despite improvements in treatments for obesity
(particularly newly-approved terzepatide, whose targets both have support from our prior genetic studies),
obesity remains a pressing public health need, and the most effective therapies carry significant risks and cost.
Our prior and ongoing genome-wide association studies (GWAS) have implicated both known and novel genes
for anthropometric traits, including measures of obesity and height (the classical model polygenic trait).
However, translating genetic discovery into new biology and actionable mechanistic hypotheses remains
challenging. Fortunately, improved tools and new resources now enable more rapid progress on the journey
from genetic discovery to biological knowledge. We can benchmark and therefore rationally select powerful
computational tools and data sets that, especially in combination, more precisely implicate causal variants,
genes, and pathways. Newly available and much larger studies of rare variation, especially coding variation,
also help pinpoint relevant genes. Whole genome sequence data sets now allow queries of structural variants
whose often large effect sizes can reveal regulatory effects on causal genes. Expanded sample sizes for non-
European ancestries will increase power and permit a broader delineation of the phenotypic consequences of
causal variants. Functional studies can test hypotheses emerging from genetic and computational analyses,
especially if the functional assays are shown to be relevant by benchmarking them against genetic data.
This proposal builds on the ongoing, successful and global collaborations we established within the GIANT
consortium, which led to discovery of most of the common variants known to be associated with
anthropometric traits. We will leverage new collaborations and newly available genetic resources, with larger
and more diverse sample sizes. By covering the range of variants - common and rare, coding, noncoding, and
structural - we will more completely define the genetic basis of measures of obesity (BMI and WHR) and
height. We will use data-driven approaches to benchmark and select computational methods (to turn genetic
data into hypotheses about causal variants, genes, and mechanisms) and functional assays (to test these
hypotheses). Finally, we will examine, in diverse populations, the phenotypic and metabolic implications of
polygenic risk scores composed of associated variants (including meaningfully selected subsets). Our proposal
will also address as yet unanswered questions about the genetic architecture of polygenic traits, using novel
approaches to study sex differences and genetic interactions.

Public health relevance
Most common diseases and medically important traits are influenced by a combination of many genes; one of these, obesity, is a pressing public health problem for which there are still few long-term effective and safe treatments. Discovering and understanding the genetic variation that influences the risk of obesity would provide new biological clues to guide better treatments. We plan to (1) use and expand our successful studies of the genetics of human height, a model trait, to chart out the best path to expand our studies of the genetics of obesity, (2) expand our already world-leading genetic studies of obesity and height to include more diverse and informative types of genetic variation studied in larger, more diverse sets of people, and (3) use new, innovative methods that combine genetic and other large data sets to better understand the biology that is implicated by these genetic studies.